Immune Responses in Neuronal Cell Death

Retinal ganglion cells (RGCs) are the only output neurons that relay visual signals from the eyes to the brain.
RGC death is a crucial element in the pathogenesis in many retinal diseases leading to blindness, such as
glaucoma and optic nerve injury. These diseases are also the leading causes of blindness of veterans. The
prevalence of blinding diseases in veterans is very high and about 20.5-63.4% of veterans were diagnosed with
at least one ocular disease. A significant cause of vision defects of VA patients is traumatic optic neuropathy
(TON) related to traumatic brain injury (TBI). TBI is a significant cause of death and disability worldwide, and it
is estimated 1.6-3.8 million new TBI cases occur in the US each year. About 57-66% veterans with TBI had
vision problems and no treatment for TON is more effective than observation. Therefore, the treatment of vision
impairment related to TBI is a significant challenge for the VA healthcare system, and it has been limited by
incomplete understanding of the molecular mechanisms that mediating the RGC death in these diseases. In
addition to the primary injury, secondary injuries dramatically worsen the damage and cause about 40% of TBI
deaths. One of the significant secondary injuries of TBI and TON is glutamate excitotoxicity, the pathological
process by which neurons are damaged and eventually killed by excessive stimulation of glutamate receptors.
This process also plays critical roles in other neurodegenerative diseases, such as glaucoma, which specifically
injure RGCs. Therefore, effectively minimizing or preventing glutamate excitotoxicity is crucial to reduce RGCs
death and preserve vision. Based on the understanding of the mechanisms which control the vulnerability of
RGCs, we plan to develop novel treatment strategies to prevent RGC death in these diseases.
Recent studies have shown that immune molecules play essential roles in neuron repair and cell death in
CNS diseases. In the retina, the receptors of major histocompatibility complex (MHC) class I molecules, T-cell
receptor, (TCR) and their associated proteins are expressed by RGCs. The mutation of these molecules reduced
the susceptibility of RGCs to glutamate excitotoxicity and optic nerve crush (ONC). These findings strongly
support the possibility that MHCI/TCR could protect RGCs from death. Also, the susceptibility of RGCs to
glutamate excitotoxicity and ONC vary significantly among different types of RGC and the types of pathological
insults. These results demonstrate that multiple mechanisms regulate the death of RGCs and, therefore, the
treatment strategies to prevent RGC death in diseases need to be designed accordingly.
In this study, we plan to conduct proof-of-principle studies to establish the role of MHCI-TCR as a critical
mediator of neuronal injury induced by glutamate excitotoxicity and ONC. Our preliminary results showed that
susceptibility of RGCs to NMDA excitotoxicity and ONC is RGC type-dependent, mutation of CD3z significantly
reduces the susceptibility of RGCs, pharmacological inhibition of Src family member, Hck, and ZAP70 protects
RGCs, and RGCs express both Hck and ZAP70. We will further determine whether Hck protects RGCs through
CD3z activation, whether the protective efficacy of Hck and ZAP70 inhibitors on RGCs is type specific, and
whether systemic application of the inhibitors protects RGCs as effective as an intraocular injection (Aim 1). We
will also determine whether the protective efficacy of the inhibitors of Hck and ZAP70 on RGCs in ONC is RGC
type-dependent (Aim 2). Finally, we will prove the principle of whether the co-application of inhibitors of Hck or
ZAP70 with a mGluR1 antagonist protects RGCs synergistically and to establish the optimal strategy for RGC
protection (Aim 3). The research will use state-of-art pharmacological, genetic, cellular, imaging,
electrophysiological and behavioral approaches, which has several unique advantages: it is grounded in a robust
yet entirely novel mechanistic framework built on current neuroscience, it targets multiple ocular injuries and
diseases commonly seen in VA patients, and may lead to a novel therapeutic strategy relevant to several eye
diseases and TBI in veterans.

Public health relevance
Retinal ganglion cells (RGCs) are the only output neurons which relay visual signals from the eyes to the brain. RGC death is a crucial element in many retinal diseases leading to blindness in veterans, such as glaucoma and traumatic optic neuropathy (TON). Because loss of RGCs will result in irreversible loss of vision and no effective treatment is currently available, effectively minimizing or preventing RGCs death and preserving vision are significant challenges faced by the VA healthcare system. This study will conduct proof-of-principle studies to establish the role of MHCI-TCR as a critical mediator of RGC death in retinal diseases, validate the efficacy of MHCI-TCR inhibitors on RGC protection, and establish the optimal strategy for using pharmacological agents regulating multiple mechanisms involved in RGC death for neuroprotection. The results of this study could provide valuable insights into the protection of neurons in eye diseases. Therefore, the experiments proposed in this study will have important implications in developing treatment strategies for VA patients.